Assessing Impact of Cultural Diversity and Family Health History

SUMMARY
Family health history (FHH) is a critical component of genomic medicine to identify patients at risk for
hereditary conditions and to contextualize genetic testing results. Despite evidence of its clinical
importance, FHH is broadly underutilized and underappreciated in clinical care. Likewise, patients’
perceptions of the importance of FHH may be unclear and therefore, the sharing FHH on patient
intake forms is overlooked, resulting in incomplete information shared with the provider. Several
other factors may contribute to patients’ lack of completion of FHH intake forms and sharing of FHH
information with their provider including cultural factors that impact sharing of health information
among family members for some conditions, gender and age differences regarding knowledge of
FHH and sharing, literacy, and limited knowledge due to blended or non-traditional family structures.
For example, older individuals and women tend to have greater knowledge of family members’ health
status. The overall goal of the parent award is to create a flexible and scalable infrastructure for
implementing an end-to- end genomic medicine risk assessment and risk management solution that
can be disseminated to a wide range of clinical settings and patient populations. Specifically, the
project aims to define and deploy a new care delivery model known as “Genomic medicine Risk
Assessment Care for Everyone” (GRACE). The central hypothesis is that combining a FHH-driven
risk assessment program, a literacy-enhanced interface, family-oriented social networking, and a
genetic testing delivery system, will create an end-to-end risk assessment/risk management solution
that will both engage and increase the proportion of diverse patients who are identified as at
increased risk, who undergo testing, and, when appropriate, who initiate cascade screening among
relatives. The FHH software tool, MeTree, will be used as the risk assessment tool in this
demonstration project; MeTree generates reports for patients and providers. For this supplement
application, we will specifically explore cultural, family, and lifestyle factors that may impact
patients’ ability to provide complete FHH information through the MeTree tool through a
literature review and semi-structured interviews with patients enrolled in the GRACE study.
Specifically, we aim to focus on patient demographics such as race/ethnicity, culture, and
LGBTQ+ communities to better define patient barriers and contribute to the improved FHH
data collection as part of the GRACE delivery model.

Public health relevance
Public Health Relevance Despite evidence of its clinical importance, family health history (FHH) is broadly under-utilized and under-appreciated, due in large part on patients’ ability and willingness to discuss FHH. This proposal aims to explore patients’ culture, age and gender, and other factors that likely impact FHH knowledge and sharing. These data will inform revisions to the FHH tool and development of educational resources to promote more complete data collection.